CNS PROCESSING OF SENSORY INFORMATION IN IBS AND FIBROMYALGIA

To determine the sensations of the rectum and arm after being stimulated, how the brain reacts to these sensations and how sleep may be affected by these sensations.